Pediatric Infectious Diseases Research Training

This application requests support for a training program that prepares highly qualified pediatricians to assume
leadership positions as investigators in Pediatric Infectious Diseases. Based in the Division of Infectious
Diseases at Boston Children’s Hospital, the program takes advantage of the rich academic and research
resources of Harvard Medical School, Harvard T.H. Chan School of Public Health, and affiliated teaching
hospitals to bring together outstanding didactic experiences and research opportunities relevant to infectious
diseases of children. Support for three positions per year is requested. Pediatricians enter the program for a
minimum of three years of integrated clinical and research training that includes at least two years of
supervised research under the mentorship of a member of the teaching faculty. The 31 members of the
teaching faculty are accomplished investigators and experienced mentors chosen from the Division of
Infectious Diseases at Boston Children’s Hospital and affiliated units at other Harvard institutions. Under the
guidance of the research mentor and the Program Steering Committee, an individualized curriculum is
designed for each trainee in one of three broad areas of investigation: microbial pathogenesis, host response
and vaccines, or epidemiology and health outcomes. Trainees in the epidemiology and health outcomes
pathway have the opportunity to earn a Master of Public Health degree from the Harvard School of Public
Health as an integral part of the training program, providing training in epidemiology, biostatistics, clinical trial
design, and analytical methods. Additional specialized training in infection control, antimicrobial stewardship, or
transplant infectious diseases is also offered. All trainees have seminars and tutorials in grant preparation and
scientific writing that supplement the mentored research experience. An individual Scholarship Oversight
Committee is appointed for each trainee to monitor progress and to provide career guidance. During the
second or third year, trainees are expected to present their work at national meetings, to prepare one or more
manuscripts for publication, and, in most cases, to apply for a K08, K23, or other career development award to
support the transition to independence as an investigator. Over the past ten years of the Pediatric Infectious
Diseases fellowship program, 27 of 30 graduates have remained in academic positions, with 15 involved in
research-based investigation, and 12 involved in primarily clinical academic activities.

Public health relevance
The goal of the training program is to train pediatricians for careers as investigators who will address the present and future challenges of childhood infections. Academic physicians with research interests in Pediatric Infectious Diseases are urgently needed to meet the ongoing and emerging threats to child health of the Covid- 19 pandemic, congenital HIV infection, childhood malaria and tuberculosis, diarrheal diseases, and respiratory infections—critical problems that are further complicated by increasing antimicrobial resistance, emerging infectious diseases, and societal opposition to childhood vaccines.